GLUCOSE UTILIZATION IN LOW BIRTH WEIGHT NEWBORNS DURING PARENTERAL NUTRITION

To determine the 1). effect of glucose infusion and amino acids on glucose kinetics in LBW 2). effect of glucose, amino acids and intralipids combined on glucose kinetics in LBW.